Task A90: Establishment of a Model of Nipah Virus Infection for Assessment of Medical Countermeasures Efficacy

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.